Epigenetics Embedding of Oral Feeding Skill Development in Preterm Infants

PROJECT SUMMARY/ABSTRACT
Preterm infants admitted to the Neonatal Intensive Care Unit (NICU) endure a multitude of stressors. Early life
stress may exceed their adaptive capacity and impede achievement of developmental milestones, such as oral
feeding. Up to 70% of NICU preterm infants are challenged to feed orally, leading to failure to thrive, prolonged
hospitalization, and high healthcare costs up to $200K per infant. There is considerable variation in the clinical
progression of oral feeding skill development across preterm infants, with some infants having more difficulty
than others. Robust evidence demonstrates that oral feeding skills require intact neurobehaviors. Early life
stress disrupts neurobehavior development, which may compromise achievement of oral feeding skills. Yet,
the extent to which early life stress impairs oral feeding skill development and the biomechanism whereby this
occurs are unknown. Exposure to early life stress during sensitive periods of neuroplasticity results in
epigenetic imprinting of stress response systems. Early life stress results in epigenetic modification of
glucocorticoid-related genes, i.e., DNA methylation (DNAm) of NR3C1 and HSD11B2, which alters
hypothalamic pituitary adrenocortical (HPA) regulation of cortisol levels and cortisol reactivity, disrupting
neurobehaviors. Epigenetic modifications due to early life stress are durable and may affect infants’ health far
beyond the neonatal period, increasing risk for life-long maladaptive feeding behaviors and poor health. The
purpose of this study is to determine the extent to which early life stress, reflected by DNAm of NR3C1 and
HSD11B2 gene promoters, compromises oral feeding skill development. In this prospective longitudinal study,
we will enroll 60 clinically stable preterm infants (28-32 weeks gestational age). We will evaluate early life
stress, DNAm of NR3C1 and HSD11B2 gene promoters, cortisol reactivity, neurobehaviors, and oral feeding
skill development during NICU stay and at 2-weeks post-discharge. The following specific aims will be
addressed. Aim 1. Determine the association among early life stress, cortisol reactivity, and oral feeding skill
development. Aim 2. Determine the extent to which DNAm of NR3C1 and HSD11B2 is associated with cortisol
reactivity and/or neurobehaviors. Aim 3. Determine the association among early life stress, DNAm of NR3C1
and HSD11B2, and oral feeding skill development. The proposed study will positively impact neonatal care by
contributing novel knowledge that clarifies biobehavioral mechanisms whereby early life stress compromises
progression of oral feeding skill development. The findings hold significant promise to identify modifiable
processes that can be targeted to promote optimal oral feeding, better nutrition, and lower risk for life-long
maladaptive eating behaviors.

Public health relevance
PROJECT NARRATIVE Preterm infants often have challenges to feed orally, leading to growth and developmental delay, prolonged hospitalization, and increased health care cost. The ability to feed orally is dependent on neurobehaviors, which can be impaired through epigenetic modifications that occur in response to early life stress exposure. Understanding the role of stress-related epigenetic modifications in oral feeding skill development can guide future development of strategies to promote successful oral feeding and nutrition, reduce post-discharge feeding difficulties, lower risk for life-long maladaptive eating behaviors, and decrease health care cost.